Core C: Functional Epigenetics Core

The Projects of this Program have research strategies that variously involve genome-wide analysis of
cancer cell epigenomes and transcriptomes and the use of screens involving genome editing. The
primary objective of the Functional Epigenetics Core is to support the PO1 Projects with expertise in
epigenetics approaches and CRISPR screens. The specific aims of the Functional Epigenetics Core
achieve this by providing the Program with the experimental and computational capabilities required
to meet these essential programmatic needs. The Core is directed by Dr. Henry W. Long, an
experienced, highly productive laboratory scientist based at the Center for Functional Cancer
Epigenetics at the Dana Farber Cancer Institute in Boston. Dr. Long has a history of innovation in
providing the critical resources and services to research projects in prostate and other cancers over
the past 5 years at the CFCE. The Core is co-led by Dr. X Shirley Liu, a highly cited and productive
computational biologist and biostatistician also based at the Dana Farber Cancer Institute. Dr. Liu has
a very strong track record of innovation in epigenetics and CRISPR screening. The Aims are 1)
Support CRISPR screening approaches; 2) Provide capabilities and resources for performing
complex epigenetic experiments; 3) Analysis and integration of epigenetic datasets; 4) Data sharing
and management.

Public health relevance
The primary objective of the Functional Epigenetics Core is to support the PO1 Projects with expertise in epigenetics approaches and CRISPR screens. The specific aims of the Functional Epigenetics Core achieve this by providing the Program with the experimental and computational capabilities required to meet these essential programmatic needs. The Core is directed by Dr. Henry W. Long, a highly productive laboratory scientist, and by Dr. X Shirley Liu, a renowned computational biologist and biostatistician with a track record of innovation in epigenetics and CRISPR screening.